Co-creation of digital tools to enhance young adult minority participation in COVID-19 trials

PROJECT SUMMARY/ABSTRACT
Increasing young adult racial and ethnic minorities’ participation in COVID-19 clinical trials is an essential
component of reducing health disparities in the uptake of COVID-19 vaccinations and treatment burden. Yet,
several obstacles hinder racial/ethnic minority participation in trials, including structural barriers associated with
lack of financial resources, access and transportation issues, and group-specific issues such as mistrust of the
medical/research community or concerns about medical experimentation. Although extensive research has
focused on addressing the low participation of minority and underrepresented communities in clinical research,
meeting 21st century goals of creating inclusive clinical trials that are representative of rapidly changing and
increasingly diverse patient demographics in the United States remains a significant challenge. The proposed
project is novel and fills a critical research and innovation gap by directly addressing the complex intersectionality
of COVID-19 clinical trials and health equity using several interdisciplinary methods of inquiry. The objective of
the proposed project is to utilize novel approaches involving big data, machine learning, data science, and
community-driven qualitative research to develop and evaluate a digital tool to encourage young minority adults
to participate in the clinical trial process. Through data mining and geospatial analysis of ClinicalTrials.gov,
insights into which communities in the United States are underrepresented in the context of access to COVID-
19 clinical trials will be developed (Aim 1), while big data and machine learning approaches will be used to
characterize user self-reported knowledge, attitudes, and lived experiences related to COVID-19 on social media
platforms (Aim 2). Focus group discussions will be used to engage in deep exploration of specific rationalities,
cultural norms, and historical influences related to COVID-19 clinical research engagement with minority young
adults (Aim 3). Data collected from these multiple sources will serve as the basis of a protocol to ideate, co-
create, and jointly design a digital health tool to encourage clinical trial participation among young adult minority
populations through co-design sessions and pilot testing held with racial/ethnic minority young adults (Aim 4).
The efficacy of the digital health tool will be evaluated by conducting a controlled before-and-after study among
a population of young adult college students at a university designated as a Minority Serving Institution (Aim 5).
The proposed project will result in a digital health tool designed to increase young adult participation in COVID-
19 clinical trials.

Public health relevance
PROJECT NARRATIVE Increasing young adult racial and ethnic minorities’ participation in COVID-19 clinical trials is an essential component of reducing health disparities in the uptake of COVID-19 vaccinations and treatment burden. Yet, several obstacles hinder racial/ethnic minority participation in trials, including structural barriers associated with lack of financial resources, access and transportation issues, and group-specific issues such as mistrust of the medical/research community or concerns about medical experimentation. The proposed project will use novel approaches involving big data, machine learning, data science, and community-driven qualitative research in order to develop and evaluate a digital tool to encourage young minority adults to participate in the clinical trial process.